Methods Incubation Core

PROJECT SUMMARY — METHODS INCUBATION CORE (MIC)
The objective of the proposed Mental Health, Earlier (MHE) ALACRITY Research Center is to reduce prevalence
and burden of mental illness via earlier intervention within real-world health care delivery systems. The central
methodological challenge is equitable implementation of evidence-based mental health innovations that aligns
with the needs and resources of community-based pediatric primary care systems and the diverse communities
they serve. The Center's Methods Incubation Core (MIC) will facilitate innovation and testing of solutions to
challenges that have inhibited translation of evidence-based tools and preventive interventions within pediatric
primary care systems. Achieving the objective of the MHE Center will be realized through transdisciplinary meth-
odologic integration grounded in implementation and prevention sciences, leveraging health information tech-
nology (HIT), and using developmentally sensitive, pragmatic measurement tools and calculators that are feasi-
ble and scalable. The MIC brings together experts in critical methodologic areas to perform two foundational
functions for the MHE Center: (1) innovate and apply implementation science, HIT, and pragmatic measurement
and analytic methods to improve implementation of evidence-based interventions to detect and prevent mental
health problems at the earliest phase of the clinical sequence and (2) provide integrated and consistent meth-
odologic support across the Center's Research Projects (RPs), the Signature Project (SP), and the Pilot Projects.
The MIC specific aims are: Aim 1: INNOVATE: Serve as a hub for cross-project methodologic synergies to
advance the science of equitable implementation in pediatric learning health systems. The MIC will be at the
nexus of identifying, developing, and disseminating novel methods (e.g., the roll-out implementation optimization
design), while highlighting unique transdisciplinary advancements facilitated by the Center's collaborative struc-
ture. Aim 2: SUPPORT: Ensure methodologic support for the Center's research activities. The MIC is charged
with ensuring that the Center's projects and research activities have excellent methodologic support to carry out
their aims and for the Center as a whole to achieve its overall research and training aims. We will provide multi-
disciplinary methodologic support, pulling from investigators' expertise in implementation and behavioral science
theories, models, and frameworks; human-centered design; HIT; and measurement science. The MIC is struc-
tured as a platform for transdisciplinary expertise to coalesce around novel methodologic challenges as they are
encountered to offer practical means of keeping projects moving. Aim 3: RDoC APPLICATIONS: The MIC will
lead testing, application, and extension of RDoC principles for testing prevention implementation and intervention
mechanistic hypothesis in the context of routine care, centered on novel implementation strategies to advance
mental health promotion and the mediators and moderators of a transdiagnostic intervention targeting irritability
and self-regulation via parenting. The MIC will allocate necessary methodologic expertise and Core resources
to address emerging and anticipated challenges and opportunities in near real time.